Training Partnerships to Prevent Hazardous Releases and Exposures

Program Summary/Abstract (HWWTP) The Steelworkers Charitable and Educational Organization (SCEO), the non-profit (501c3) arm of the United Steelworkers (USW), is applying for HWWTP funds to support a training partnership linking two of the largest U.S.-based industrial unions with rapidly expanding immigrant worker centers. The Tony Mazzocchi Center (TMC), the SCEO's training entity, brings together the USW, the Communications Workers of America (CWA), the Labor Institute (LI), the National Day Labor Organizing Network (NDLON) and Make the Road New York (MRNY). This proposed partnership will conduct 2,745 courses and reach 55,950 workers, managers and community residents with 633,700 hours of HWWTP training over the five-year grant period.

Public health relevance
HWWTP: Project Narrative The TMC will conduct 2,745 courses to reach 55,950 workers, managers and community residents with 633,700 hours of HWWTP training over the five-year grant period. We have direct access to over 1.2 million USW/CWA workers and managers at facilities located in each U.S. state as well as Puerto Rico, Guam, and the Virgin Islands. Approximately, 850,000 of these workers are potentially exposed to hazardous substances covered by OSHA Standard 29 CFR 1910, EPA 40 CFR 311, and DOT 49 CFR 171-177. In partnership with Make the Road New York (MRNY) and the National Day Laborer Organizing Network (NDLON), we will train day- laborers and temporary workers employed in virtually every kind of clean-up activity, in addition to construction, car washes, cleaning, home care, warehousing and distribution. MRNY has over 16,000 members at its five NY centers and NDLON is a network of 45 day-laborer organizations in fifteen states.